Synthesis and Chemical Biology of Thiopeptide Antibiotics

PROJECT SUMMARY/ABSTRACT
Antibiotics have transformed the human health and disease landscape. However, the use and
misuse of such antimicrobial drugs accelerate the emergence of bacterial strains resistant
against antibiotics, so that standard treatment options eventually become ineffective. In light of
these critical needs, thiopeptides have emerged as a promising platform for the discovery of
new therapeutic leads. In Aim 1, we will develop and optimize the preparation of 26-membered
thiopeptides by inventing a new cyclodehydration methods to facilitate the synthetic campaign.
The methods established in this aim will be validated in the context of representative
azole/azoline-containing antimicrobial peptides. In Aim 2, we will optimize a streamlined
synthesis of 35-membered thiopeptides by integrating Mo-catalyzed cyclodehydrations and site-
selective Dha mutations. These findings will unlock the translational potential of a previously
unexplored class of potent antibiotics. In Aim 3, we will develop an automated platform for
rational thiopeptide design and modifications, and integrate it with microbiological, biophysical,
and computational studies to generate promising leads suitable for pre-clinical and clinical
investigations. Successful realization of the abovementioned aims will establish innovative tools
for the synthesis of thiopeptides and other bioactive macrocyclic peptides. Because of the
importance of azol(in)es as the key structural elements in bioactive natural products of
biomedical relevance, the discoveries of this study will have a transformative impact on the
development of new therapies.

Public health relevance
PROJECT NARRATIVE The growing numbers of antimicrobial-resistant pathogens place a significant burden on healthcare systems and have important global economic costs. In this project, we will study thiopeptide antibiotics and develop a predictive model for the identification of potent antimicrobials against ESKAPE pathogens. The results of this study will have a transformative impact on the treatment regimens and will generate new candidates for pre-clinical and clinical studies.